Multi-Channel Communication for Improvements in Cancer Education and Outcomes (MICEO) in Underserved Populations

PROJECT ABSTRACT
Childhood cancer survivors are a high-priority, underserved population for HPV vaccination. They are less
likely to be vaccinated when compared to the general population and are more likely to develop second
cancers caused by HPV as adults. St. Jude Comprehensive Cancer Center (SJCCC) is uniquely positioned to
address observed disparities in HPV vaccination coverage among childhood cancer survivors by leveraging
our unique reach across our catchment area and building on award-winning, state-of-the-art communication
systems with those treated at SJCCC and their families. The overall goal of the proposed administrative
supplement is to improve HPV vaccination coverage among childhood cancer survivors. The specific aims are
to: (1) develop an innovative, culturally targeted, multi-channel educational campaign to enhance health
literacy related to HPV vaccination and to improve HPV vaccination coverage among childhood cancer
survivors; and (2) pilot test the multi-channel educational campaign to understand its impact on knowledge and
intention and to inform the next steps. Our proposed plan will build on established and newly developed patient
families and survivor-facing educational resources in English and Spanish, which are designed and
disseminated to promote and facilitate health literacy. Our approach will be highly iterative and include
engagement of key offices within St. Jude, including SJCCC Community Outreach and Engagement, HPV
Cancer Prevention Program, Strategic Communication, Education and Outreach, Patient Family Centered
Care, Patient Experience Office, Transition Oncology Program, After Completion of Therapy Clinic, and most
importantly, through our regular interaction with patient families and childhood cancer survivors through the
Patient Family Advisory Council and additional patient family advisors. The multi-channel campaign will focus
on web-based resources and communities, social media platforms, Our St. Jude mobile application (app),
traditional print formats, electronic medical record prompts for prescribed patient education, and peer-to-peer,
patient family champion experiences. We will target the 10-30-year-old age group with approaches
differentiated by 10-17-year-olds for whom parent/caregivers make vaccination decisions and 18-30-year olds
who can make vaccination decisions for themselves, in most instances. We will develop and pilot test an HPV
vaccination campaign across these multiple channels. Our project activities will be documented and monitored
through a comprehensive process evaluation. The preliminary impact of our efforts will also be measured using
qualitative, quantitative, and analytical data, including assessment of aggregated HPV vaccination rates before
and after the campaign implementation period. Our efforts will be aligned with St. Jude communication and
educational resources from the beginning to optimize sustainability. We will openly share our findings with
other cancer centers and organizations serving childhood cancer survivors and continue to refine and test our
approaches to ensure we are achieving impact through increased HPV vaccination coverage among childhood
cancer survivors.

Public health relevance
PROJECT NARRATIVE Childhood cancer survivors are a high-priority, underserved population for HPV vaccination because they are less likely to be vaccinated and more likely to develop second cancers caused by HPV as adults when compared to the general population. This project will use an iterative, participatory, and collaborative approach to leverage, build on, and enhance existing and introduce new communication channels to reach patient families with an innovative, multi-channel educational campaign.